Identification of novel MDR antimicrobials from symbioses between terrestrial and marine invertebrates and rare microbial taxa

ABSTRACT
The goal of this CETR is to use a combination of innovative strategies to combat drug resistant infectious
diseases. In particular, we will use cutting edge methods in metabolomics and genomics to discover lead
small molecules targeting the most problematic multi-drug resistant (MDR) Gram-negative bacterial and
fungal pathogens. This project, Project 2 (P2), will develop and implement a metabolomics pipeline that
will also serve Project 1 and Project 3. We will integrate bioassay data from multiple pathogens exhibiting
diverse drug resistant phenotypes to supplement our metabolomics data. Essentially, we will employ
metabolomics-driven pipeline to identify novel molecules with target efficacy both in vitro and in vivo
againswhile also lacking host toxicity traits. To identify and access chemical diversities that will drive this
project, we will target symbiotic microbes associated with i) marine invertebrates, and ii) insects; in all
cases a particular focus will be placed on rare bacterial genera. Additionally, we seek answers to basic
questions underpinning these new strategies and their high success rates relative to historical discovery
approaches. To answer these questions and discover the next generation of antimicrobials, projects P1,
P2 and P3 share three identical specific aims; Aims 1-3 all focus on how symbioses provide novel bacteria
as sources for new compound discovery with in vivo efficacy against MDR pathogens. Support for this
project will be supplied by four scientific cores (Chemistry, In Vitro, In Vivo, and Mechanism of Action).
The outcome of this project will be novel antimicrobial small molecule leads with in vivo efficacy against
MDR pathogens and host safety.

Public health relevance
NARRATIVE Drug resistant infectious diseases now represent the greatest threat to human health worldwide. The best source of drug leads to treat infectious diseases has been natural products from microbial sources. We will use co-evolved bacteria and innovative strategies to identify and exploit urgently needed new sources of antibacterial and antifungal agents to combat this health threat.